AB SCIEX QTRAP 7500 LC MS/MS

Project summary
This application is for funds to purchase the AB SCIEX QTRAP 7500 LC-MS/MS. This mass
spectrometer has important performance features that distinguish it from other instruments available on
campus and from other instruments available on the market and will enable us to perform high-end
experiments for small molecule quantitation. The QTRAP 7500 offers state-of-the-art technology for
quantitation, identification, and structural analysis of small molecules. The main features we require
include an electrospray ionization source for small sample amounts obtained from dissected tissues,
extracellular vesicles or tissue culture; the APCI (Atmospheric pressure chemical ionization) source as
an alternative ionization source to optimize MS/MS spectra for certain molecules; an ultra-high pressure
liquid chromatography (uHPLC) interface for tandem mass spectrometry (MS/MS), the ability to perform
in two operating modes (triple quadrupole and linear trap), and to switch quickly between them, a fast
scan rate, the ability to perform quantitative measures of small molecules using selected reaction
monitoring (SRM) and multiple reaction monitoring (MRM), and the ability to identify and quantify
bioactive lipids. The QTRAP 7500 excels in each of these areas and is the instrument chosen. We will be
able to solve challenging analytical problems and identify and quantify small molecules, such as lipids,
hormones and environmental contaminants and their metabolites related to disease. Most of the users of
the instrument are already collaborating in projects, thus this will help solidify their scientific interactions.
Twelve investigators with major research projects, eleven with NIH RO1 support and one with NIOSH
support, and six investigators for five minor research projects require the sensitivity and high throughput
ability of the QTRAP 7500 mass spectrometer to answer important questions. We have developed
preliminary data for many of the projects. Of the major projects, three involve analysis of environmental
contaminants, pesticides, or opioids in small tissue samples (Vulpe, Denslow and Bolser), eight involve
analysis of bioactive lipids (Baker, Alli, Vulpe, Denslow, Swale, Vite, Moore, and Wise) and four require
analysis of hormones (Baker, Reznikov, Yue and Jones). The minor users fall within these same general
methods but also require analysis of PFAS in fish or of harmful algal bloom toxins in cells in tissue
culture. Many of the projects, but in particular the projects requiring lipidomics analyses, will require
multiple reaction monitoring (MRM). Both Electrospray (ESI) and Atmospheric Pressure Chemical
Ionization (APCI) will be required for the projects. These projects will result in better understanding of
fundamental processes that lead to the potential treatment of diseases in humans.

Public health relevance
Project Narrative The instrument we wish to purchase, the AB SCIEX QTRAP 7500 LC-MS/MS, will enable researchers to measure low levels of bioactive lipids, hormones, and environmental contaminants in cell culture and tissues of model organisms. Identification and quantification of these molecules will advance our knowledge in several medical fields including a better understanding of how pesticides and opioids affect disease and will enable us to measure minute amounts of sex steroid hormones and thyroid hormones in tissues and blood. We expect that with the results we obtain from our studies, we will be better able to understand human disease and begin to find ways in which to improve health.